A Training Program to Address HIV-related Health Disparities in MSM

ABSTRACT
The HIV epidemic in the United States remains a critical public health concern, particularly for multiply
marginalized populations such as Black men who have sex with men (Black MSM) and Black trans women. In
the U.S., MSM experience a disproportionate burden of HIV infection, accounting for over two-thirds of new
cases. There is a profound need to design and test biobehavioral HIV prevention interventions for MSM and
trans women, particularly those who are Black, using intersectional approaches. Given the high burden of
intersectional stigma reported by Black MSM and trans women and its negative effects on HIV-related
healthcare uptake, biobehavioral HIV prevention for Black MSM and trans women will require an intersectional
stigma framework, specific to their interfacing with healthcare settings, to be optimally effective. Challenges
associated with the creation and uptake of combination prevention responses will certainly not be overcome
unless we continue to invest in the training of new generations of scholars who are committed to ending the
epidemic among MSM. This application requests support for the five-year continuation of our NIMH-funded
institutional training grant, “A Training Program to Address HIV-related Health Disparities in MSM”. This
training program has been designed with the goal of providing trainees with the necessary skill sets to not only
launch their careers, but also to make a substantial difference in the fight against HIV/AIDS among MSM. This
program is grounded within a leading School of Public Health, a research environment that is not only rich in
terms of HIV prevention research but also has a strong tradition in LGBT health research, with robust
theoretical and empirical approaches to explaining risk among MSM and a strong focus in HIV global health
and bio-behavioral research. This creates an ideal environment to train the next generation of HIV prevention
scientists who will address the epidemic among MSM. Continuation of a T32 training program within this
extraordinarily rich environment will continue a mechanism to mentor the next generation of HIV prevention
scientists who will be uniquely poised to find ways to end the epidemic among MSM.

Public health relevance
PROJECT NARRATIVE This application requests support for the five-year continuation of our NIMH-funded institutional training grant, “A Training Program to Address HIV-related Health Disparities in MSM” seated within a leading School of Public Health, a research environment rich in HIV prevention research, LGBT health research, theoretical and empirical approaches to explaining risk among MSM, and HIV global health and bio-behavioral research, all creating an ideal environment to rain the next generation of HIV prevention scientists who will address the epidemic among MSM. This training program has been designed with the goal of providing trainees with the necessary skill sets to not only launch their careers, but also to make a substantial difference in the fight against HIV/AIDS among MSM. Continuation of a T32 training program within an extraordinarily rich environment will continue a mechanism to mentor the next generation of HIV prevention scientists who will be uniquely poised to find ways to end the epidemic among MSM.